Characterizing a Serine-Threonine Phosphatase Essential for Asexual Replication in Plasmodium falciparum

Abstract
While we have made significant progress toward malaria eradication, further attempts are hampered by the fact
that little is known about the basic cellular biology of Plasmodium falciparum, the causative agent of malaria. In
the asexual stage, where the parasite replicates in red blood cells and causes malaria’s characteristic cyclical
fevers, a contractile ring structure known as the basal complex is required for replication and serves to separate
budding daughter cells. I have identified a member of the basal complex that is essential for parasite growth and
division, PfPPPP8, and acts as a serine-threonine phosphatase. PfPPP8 is the only basal complex protein with
known enzymatic activity, and I believe PfPPP8 is essential to drive the formation and organization of the basal
complex during asexual division. To determine whether its phosphatase activity makes PfPPP8 essential, I aim
to use genetic complementation. I will use CRISPR-Cas9 to insert an exogenous copy of PfPPP8, with mutations
in predicted key catalytic residues, into a PfPPP8 inducible knockdown line, knock down the endogenous copy,
and determine the impact of each mutation on parasite growth and division. To further characterize PfPPP8’s
role in division, I will perform quantitative phosphoproteomic analysis in the same inducible knockdown line and
identify PfPPP8’s enzymatic substrates. These substrates will themselves be genetically modified with an
epitope tag and a knockdown system so their localization throughout Plasmodium division can be visualized and
the phenotypic consequences of their absence can be compared to the PfPPP8 knockdown phenotype.
To identify novel basal complex proteins using PfPPP8, I performed immunoprecipitation on PfPPP8 and another
epitope tagged basal complex protein PfCINCH in the PfPPP8 inducible knockdown background. I will select
proteins which, based on their absence or depletion in the PfPPP8 knockdown condition, are likely to be
uncharacterized members of the basal complex, prioritizing those which are predicted to be essential, and
introduce similar genetic modifications as the putative substrates to determine if they also localize to and are
required for the formation of the basal complex. I will also similarly select and examine top candidate proteins
only present in the PfPPP8 pulldown, which are likely to be specifically relevant to PfPPP8, in order to further
characterize PfPPP8’s mechanism of action and role within the parasite throughout division. Because PfPPP8
is essential to Plasmodium growth and replication during the pathogenic stage and because it is conserved only
among Plasmodium species, further study could prove it a useful new target for developing antimalarials in the
face of rising resistance to extant drugs.

Public health relevance
Project Narrative The parasite which causes malaria uses a unique, specialized structure known as the basal complex to separate daughter cells during division. We identified a serine-threonine phosphatase involved in the basal complex which is essential for parasite growth and replication. Our goal is to identify and characterize this protein and its substrates and other interactants to determine the role it plays during the division process, as it could be an effective target for developing new anti-malarial drugs.